ECM regulation and neuronal plasticity in mice harboring a common risk allele for Alzheimer's

Abstract
The three human alleles of Apolipoprotein E (APOE) differentially impact individual risk for Alzheimer’s
disease (AD), with the APOE4 allele significantly increasing risk in a dose dependent manner. The mechanisms
by which APOE4 elevates AD risk are not fully understood. As compared to other alleles, APOE4 may reduce
clearance of amyloid-β (Aβ) from the central nervous system. Moreover, in mice with targeted replacement (TR)
of APOE or APOE3, APOE4 TR mice show a relative reduction in dendritic complexity and impaired learning.
This is significant in that these mice do not deposit Aβ, suggesting that APOE4 might independently reduce
cognitive reserve and thus enhance vulnerability to AD and cognitive decline. Consistent with this is a more
recent study of sharp wave ripple (SWR) abundance, in which SWR abundance was reduced in APOE4 TR
mice. SWRs are events in which assemblies of hippocampal neurons, sequentially activated as a function of
time and place during a learning experience, are sequentially replayed in an accelerated fashion during quiet
restfulness and slow wave sleep. Replay is critical to memory consolidation and to transfer of hippocampal
encoded experience to cortical areas for long term storage. Accumulating evidence suggests that deficits in
neuronal plasticity, including reduced pyramidal cell arborization and SWR abundance, may be due in part to
alterations in brain extracellular matrix (ECM) including perineuronal nets (PNNs). PNNs are a specialized form
of ECM predominantly localized to the soma and proximal dendrites of gamma aminobutyric acid (GABA)
releasing parvalbumin (PV) expressing inhibitory interneurons, and they facilitate GABAergic inhibitory
transmission to constrain excitatory neuroplasticity. Indeed, maturation of PNNs coincides with the closure of
critical periods of enhanced physiological plasticity. Conversely, drugs that attenuate PNN abundance can
increase long term potentiation (LTP) of hippocampal neurotransmission, plasticity of glutamatergic
neurotransmission, cognitive flexibility and SWR abundance in adult rodents. In the present proposal, we outline
plans to test the hypothesis that APOE4 is linked to a dysregulation of the balance between PNN deposition and
proteolysis, and that it is this imbalance that leads to deficits including reduced SWR abundance. This hypothesis
is based on published and preliminary data discussed in the background. In this proposal, we also outline plans
to test the hypothesis that two FDA approved compounds, venlafaxine and maraviroc, will normalize ECM levels
and physiological changes observed in APOE4 TR mice including reduced SWR abundance. Venlafaxine is an
antidepressant medication with the potential to increase matrix metalloproteinase-9 (MMP-9) levels and
attenuate the PNN, while maraviroc is instead an antagonist for CCR5, a hypothetical regulator of the ECM. The
CCL5 receptor, CCR5, restricts LTP and post-stroke neuroplasticity, while both LTP and plasticity are instead
increased in CCL5-receptor antagonist treated mice.

Public health relevance
Narrative APOE4 is associated with cognitive dysfunction in aged individuals and increased Alzheimer’s risk. A better understanding of the mechanisms by which APOE4 could alter cognition, and whether specific therapeutics could target these pathways, is critically needed.